Immature Infant Alveloar Macrophage Clearance of Cell Debris During RSV Infection

DESCRIPTION (provided by applicant): The long-term goal of our laboratory is to better understand the age-based differences in host immunity that affect acute and chronic pulmonary disease outcomes so we can improve therapeutic and vaccine strategies for infant and elderly populations. Our current research focus is respiratory syncytial virus (RSV), an infection that causes severe disease in the very old and very young, has no available vaccine and no effective therapy. We have developed an infant mouse model of RSV infection to improve our understanding of infant versus adult host immune responses to RSV infection. It is known is that the accumulation of cellular debris and airway occlusion is a consequence of severe RSV disease and alveolar macrophages (AMs), which make up >90% of airway cells, are responsible for clearing cell debris. However, little is known about how immature infant AMs contribute to severe disease or their potential for immunomodulation to mitigate RSV pathology. The goal of the proposed work is to determine the extent to which infant AMs prolong RSV replication and impair removal of apoptotic cells during infection and if immune modulation with inhaled IFNγ mitigates these effects. We have shown that treatment with inhaled IFNγ increases AM activation, expedites RSV clearance, and reduces the number apoptotic cells and mucus in infant BALB/c mice. We hypothesize that infant AMs contribute to the accumulation of apoptotic cellular debris and prolong RSV replication due to an immature lung environment which can be mitigated with inhaled IFNγ. To test our hypothesis we will complete two Specific Aims. The first Aim is to determine the mechanisms by which inhaled IFNγ enhances the clearance of RSV, apoptotic cells (ACs), and mucus and protects against RSV-mediated airway hyperresponsiveness (AHR) in neonatal mice. Results of this aim are expected to show that mice with depleted AMs will have reduced M1 and M2c AM function which is required for clearance of ACs, delayed RSV clearance, and increased airway resistance and that IFNγ acts on AMs to resolve these effects. Specific Aim 2 will define the signals that regulate the efferocytosis of RSV-laden A549 cells by human cord and adult blood monocyte-derived macrophages with or without IFNγ priming. We expect IL-10/M-CSF polarized M2c macrophages, regardless of source, will increase AC clearance more than \ TGFß-polarized macrophages during RSV infection, but in the absence of T-cell recruitment, inhaled IFNγ will mitigate RSV-mediated impaired efferocytosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: Airway occlusion is a hallmark of severe infant respiratory syncytial virus (RSV) infection due to the accumulation of cellular debris and mucus and contributes to significant morbidity and mortality. Alveolar macrophages are largely responsible for clearing cellular debris and mucus, suggesting that alveolar macrophages may be impaired in infants with severe RSV infection. Though impaired IFNγ production is also correlated with severe disease, its relationship to mucus production and apoptotic cellular debris is unclear. The goal of this proposal is to determine if infant alveolar macrophages are responsible for the accumulation of mucus and cellular debris and the mechanism by which IFNγ enhances resolution of this debris using an infant mouse model as well as human adult and cord blood monocyte-derived macrophages.